Project 3: Maximizing Anti-tumor Activity through Simultaneous Activation of the Innate and Adaptive Immune System in Kidney Cancer

Project Summary
Immune checkpoint inhibitors (ICI) have the potential to cure patients with metastatic renal cell carcinoma (RCC).
For those experiencing a complete response (CR), induction Ipilimumab (Ipi)/ Nivolumab (Nivo) followed by
maintenance Nivo results in overall survival (OS) rates of 97% at 4 years. However, CR rates occur in ~10% of
patients. Survival rates plummet in patients with progressive disease (PD) and even stable disease (SD). Despite
Nivo maintenance, patients with SD after induction (36%) show significantly reduced 4-year OS rates (55% vs
97%). While by comparison to PD patients (OS rates ~20%), patients with SD derive some benefit from ICI, the
full potential of immunotherapy is not realized. We hypothesize that the addition of complementary immune
strategies will increase responses and eventually cure rates for patients with SD after induction. This represents
an unmet medical need. Most immunotherapy approaches to date have focused on amplifying an adaptive
immune response (i.e., ICI), but more effective strategies may result from simultaneously activating the innate
and adaptive immune arms as it normally occurs physiologically. To unleash the full potential of the immune
system, we propose to induce innate immunity by stimulating antigen presentation (through immunogenic cell
death triggered by stereotactic radiation) and promoting inflammation (with a novel STING agonist we
discovered). Pioneering research at UT Southwestern Medical Center (UTSW) identified a novel innate immune-
sensing pathway, the cGAS-cGAMP-STING pathway, leading to the Breakthrough Prize in Life Sciences in 2019
and the development of IMSA101, a novel STING agonist. A phase 1 trial of IMSA101 (NCT04020185) at UTSW
and elsewhere showed that IMSA101 is safe and active. Herein, we propose a novel adaptive clinical trial to
evaluate the impact of stereotactic ablative radiation (SAbR)/ IMSA101 added to standard-of-care (SOC) Nivo
maintenance in patients with SD following induction Ipi/Nivo to harness the full potential of the immune system.
To accomplish this goal, we will conduct a randomized phase 2 trial comparing this regimen to SOC maintenance
Nivo. The study is powered to detect a clinically meaningful difference in response rates from 5% to 35%, which
can be accomplished with 50 patients. We will explore the impact of the intervention through pharmacodynamic
studies involving not only sophisticated tissue analyses, but also an innovative PD-L1 PET. We are uniquely
positioned to carry out these studies given: (i) the discovery of the cGAS-cGAMP-STING pathway and
development of IMSA101; (ii) our pioneering development of SAbR applications for RCC with possibly the largest
SAbR RCC program globally; (iii) our prior success executing clinical trials combining SAbR with ICI in RCC
patients; and (iv) our pioneering work leveraging PD-L1 PET in renal cancer. If successful, this study will harness
the full potential of the immune system through simultaneous activation of the innate and adaptive arms of the
immune system in a patient population with modest benefit from ICI and which represents an unmet medical
need.

Public health relevance
Project Narrative Immune checkpoint inhibitor combinations have shown considerable promise, but the majority of metastatic kidney cancer patients are not cured. We propose to engage both the innate and the adaptive immune system arms to improve the outcome of immune checkpoint inhibitors for patients with metastatic kidney cancer.